Massachusetts NARMS Cooperative Agreement Program to Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens

The Massachusetts State Public Health Laboratory (MASPHL) is requesting funding from PAR-
25-014 NARMS Cooperative Agreement Program to Enhance and Strengthen Antibiotic
Resistance Surveillance in Retail Food Specimens to support laboratory capacity and testing
costs with the goal of monitoring antimicrobial resistance among enteric bacteria in raw retail
meat and seafood. MA participation promotes and protects public health by contributing to the
understanding of the burden of antibiotic-resistant pathogens in our nation's food supply.
MASPHL has the capacity and capability to meet all deliverables outlined in the cooperative
agreement. The Food Laboratory within the Division of Microbiology at MASPHL, is fully staffed
by six full time analysts. Analysts will schedule surveillance testing and collect retail meat and
seafood samples at least twice per month on non-consecutive days from pre-determined
locations. Analysts have access to reimbursed personal transportation and also use of state
vehicles to ensure timely delivery of samples under proper transport conditions. Upon sample
receipt at MASPHL, standardized microbiological testing will be performed by trained and
competent analysts in a fully equipped Food testing laboratory. MASPHL ensures quality
laboratory test results by performing testing methods accredited to the ISO 17025 standard (or
equivalent). Isolated pathogens will be extracted in the MASPHL Molecular Microbiology
Laboratory in accordance with validated PulseNet extraction protocols. Extracted nucleic acid
meeting quality control metrics will then be submitted to the Division of Sequencing and
Bioinformatics Core for Whole Genome Sequencing (WGS) and analysis. Sequences that pass
QC will be uploaded with associated metadata to NCBI following the NARMS WGS
Performance Guidelines.
MASPHL will contribute data generated from surveillance testing to include organism
identification and characterization, including speciation and serotype, retail location and food
packaging information as well as WGS data. Bacterial isolates recovered from food samples will
be submitted to FDA each month through the MASPHL Division of Central Laboratory Support
Services, which is fully staffed and ready to support isolate submission. MASPHL will actively
participate in NARMS conference call and working groups to obtain program updates and
maintain compliance.

Public health relevance
MASPHL participation in the NARMS Cooperative Agreement Program to Strengthen Antibiotic Resistance Surveillance in Retail Food Specimens project will enhance and strengthen antibiotic resistance surveillance in raw retail meat and seafood. Food samples purchased at Massachusetts retailers, screened for pathogens of interest and characterized via subsequent laboratory testing data will not only support the goal of monitoring antimicrobial resistance among enteric bacteria but also promote and protect public health by contributing to the understanding of the burden of antibiotic-resistant pathogens in our nation's food supply.